Resource Centers for Minority Aging Research National Coordinating Center (RCMARs NCC)

Project Summary/Abstract
The NIA RCMAR program was established in recognition of the value of diversity in the
research enterprise to address disparities in health and function trajectories among different
racial and socioeconomic groups. Our goal is to establish the RCMARs National
Coordinating Center (NCC) at the Gerontological Society of America (GSA), drawing upon
its infrastructure and expertise. The Specific Aims of the RCMARs NCC are:
1. Implement and expand new infrastructure to support the Centers, including an interactive
website, robust community-wide online networking platform, tools to enhance collaboration,
and resources supporting the creation of new scholarship and fostering culturally aware and
responsive mentorship and career development.
2. In partnership with NIA staff and the RCMAR Community of participating institutions,
scientists, trainees, staff, and partners – establish consensus on essential common
evaluation metrics and implement a streamlined process for collecting data to support the
evaluation of RCMAR Center activities, including research, collaboration, mentoring,
networking, stakeholder engagement, and DEIA.
3. Develop new tools and leverage existing evidence-based tools to provide trainees, early
career investigators, and mentors from diverse backgrounds with skills and technical support
necessary to advance their professional growth and diversify the research workforce in the
behavioral and social sciences to address minority aging, AD/ADRD, and/or health
disparities in older adults.
4. Catalyze resource sharing between and among the RCMAR Centers and cultivate
sustainable engagement with key stakeholders including Minority serving institutions (MSIs);
Historically Black Colleges and Universities [HBCUs], Tribal Colleges and Universities
[TCUs], Hispanic Serving Institutions [HSIs]) and other academic institutions serving
predominately racially minoritized students and groups), all NIA research Centers, the aging
research community, and the public.
5. Enhance the prominence of the RCMAR program, behavioral and social research on aging
and AD/ADRD throughout and beyond the aging field. Foster reverence for the value of DEIA
in the aging research enterprise by broadly elevating and disseminating the activities and
findings of the Centers and their scientists in academic and public venues.

Public health relevance
Project Narrative Aging is a complex issue that must not be viewed from a single lens. Older adults have the most to lose when the expertise of scientists from diverse backgrounds is absent and the most to gain from an approach that brings all perspectives to bear. The RCMAR National Coordinating Center addresses this issue by developing tools to support new researchers from diverse backgrounds and supporting a network of researchers in making scientific discoveries that eliminate health disparities and improve the health and well-being of older adults.